Leadership, Planning, and Evaluation

LEADERSHIP, PLANNING, AND EVALUATION (LPE): SUMMARY
The Hollings Cancer Center (HCC) director has integrated external advisory groups and internal committee
structures to create a coordinated and comprehensive planning and evaluation strategy to effect coordination
across MUSC, internally within HCC, with the external engagement of stakeholders across South Carolina
(SC), and with objective external advice from peers at other cancer centers. Chaired by Raymond N. DuBois,
MD, PhD and comprised of the center’s eight associate directors and the oncology service line medical
director, the Executive Council (EC) is the de facto body where decisions are made in the HCC. It provides
scientific oversight and ensures alignment across research efforts, clinical oncology practice, and impact on
clinical research and administration, creating a unified approach to realizing the center’s vision, mission, and
goals. In 2020, with input from its members and advisory entities, the EC redeveloped a five-year strategic plan
to guide the center as we advance. Six priorities emerged: 1) Power cancer discovery & innovation; 2) Deliver
innovative & patient-centered care; 3) Reduce cancer health disparities; 4) Train the next generation; 5)
Develop & maintain a diverse workforce; and 6) Position Hcc for sustained success. The EC meets monthly
with HCC program leaders and shared resource directors who comprise the Research Committee (RC). The
RC oversees and reviews research development within and among the program membership, and devises
approaches to foster transdisciplinary collaborations. Shared resource directors communicate updates to the
committee on usage, new equipment needed, service needs, and member survey results. The External
Scientific Advisory Board, made up of national leaders in oncology research and cancer center leaders, has
had a significant influence on the HCC, including strengthening the role of the Director on the cancer service
line, increased financial support from the state by $10M per year, greater institutional commitment to COE that
tripled the number of staff and funded a new Assistant Director, and alignment of the Scientific Programs. HCC
also benefits from two non-scientific community boards. The Hollings Advocacy Board influences legislative
bodies and the private sector to raise financial support for cancer prevention, care, and research, including the
acquisition of a new mobile health unit to provide education, screening, and vaccinations to citizens residing in
rural SC. The Community Advisory Board (CAB) includes a diverse group of lay community members and
patient advocates representing stakeholders in the state's civic, church, and healthcare areas. The CAB
provides input on the plans and priorities for COE, which ultimately influence the Research Programs, the
clinical trials portfolio, the education and screening intervention programs across the state. Other internal
committees that contribute to planning and evaluation include the Clinical Research Executive Committee and
the Education and Leadership Training Council. Future plans focus on nurturing recently implemented
leadership development activities, generation of our next strategic plan, and expansion of evaluation efforts.